Mayo Clinic Center for Clinical and Translational Science (CCaTS)

PROJECT SUMMARY
Parent award summary: Mayo Clinic is one of the largest and top-ranked academic health systems in
the US. The Mayo Clinic Center for Clinical and Translational Sciences (CCaTS) was created to be an engine
of translational science and innovations, envisioning to enable high-quality multidisciplinary research to
accelerate clinical trials, facilitate digital health transformation, and partner with stakeholders and communities
to improve patient care and health for all. The CCaTS was awarded a UL-1 grant (UL1TR002377-07) with the
following specific aims: simplify and accelerate the work of translation to improve health for all by advancing
clinical trial innovations and digital health transformations, streamlining methods and processes, and developing
novel informatics solutions that increase efficiency and drive implementation of discoveries that improve health
and promote health equity (Aim 1); enhance education programs through the expanded reach of competency-
based, learner-focused solutions, training a diverse, inclusive, multidisciplinary CTS workforce to be prepared to
address the urgent health care needs of all communities in a rapidly changing environment (Aim 2); engage
local community members and patients to be active partners in translational teams, expanding research
capabilities of underserved communities (Aim 3); expand national and regional partnerships and strengthen
collaborative CTS networks in all aspects of CTS and education, focusing on sharing innovative approaches and
prioritizing diversity, equity, and inclusion (Aim 4).
Diversity supplement summary: Chronic kidney disease (CKD) is a growing burden in public health
and has a significant genetic component that remains largely under investigated. Prior studies have identified
genes associated with CKD, but their effects are relatively small, and a large proportion of the remaining genetic
risk is expected to be related to rare gene variants yet to be investigated. In addition, the penetrance of
pathogenic variants (percentage of a clinical trait in carriers of pathogenic genetic variants) is not well
determined, limiting out ability to interpret the significance of a positive finding. Investigations into new genes
and on penetrance of CKD-associated genes are an unmet need to promote individualized medicine, expected
to accelerate innovations in care by allowing the identification of people at risk, mechanisms of disease, and
potential new targets for treatment and prevention. New genomic and digital resources are now available
enabling us to fulfil this gap in knowledge. By specifically aligning with the Parent Aim 1 (facilitation of digital
health transformation) and Parent Aim 2 (preparation of a diverse workforce), this Diversity Supplement intends
to:
Aim 1. To investigate rare genetic variants associated to CKD using meta-analysis of burden tests
for rare variants from four large repositories with genomic data. I will do meta-analysis of the association
of rare variants (MAF<10-3) and various CKD phenotypes in the UK-Biobank, All of Us Study, Mayo Clinic
Tapestry Study, and Mayo Biobank Study. Phenotypes tested will be estimated glomerular filtration rate, all-
cause and specific causes of CKD, end-stage kidney disease, albuminuria, and renal cysts. I will generate
computational algorithms to perform data extraction and harmonization of variables between studies, creating
an integrated system able to facilitate similar analysis. In addition, computational algorithms linking selected
variants to a set of secondary data sources will be developed to generate a map of associations to other related
phenotypes and potential therapeutic targets for drug development or repurposing.
Aim 2. To define the penetrance of pathogenic genetic variants for renal phenotypes in a panel of
CKD-related genes using four large repositories with genomic data. I will first identify pathogenic or likely-
pathogenic variants related to CKD, including those from Aim 1. For each gene, observed penetrance in UK-
Biobank, All of Us Study, Mayo Clinic Tapestry Study, and Mayo-Biobank Study will be computed. For the genes
with sample size amenable to investigation, modulators of penetrance will be investigated by comparing within
the group harboring pathogenic variants those with or without the phenotype of interest.

Public health relevance
PROJECT NARRATIVE This proposal is relevant to public health since it would: 1. Add scale to the study of genetic variants related to CKD, more particularly by having power to identify rare variants associated with this condition which has not been addressed by prior studies. By conducting gene-burden analysis in a diverse sample comprising 850,000 participants with whole-genome or whole- exome sequencing information, we will improve our ability to identify people carrying increased genetic risk related to CKD, opening opportunities for primary and secondary prevention. 2. This will be the largest study addressing the penetrance of CKD-related variants in an unbiased way. Absolute and unbiased association estimates between CKD-related variants and CKD and other renal phenotypes will be computed and stratified by age, sex, and comorbidities. These findings will be useful the interpretation of genetic variants in scenarios where the clinical trait is absent or just partially present. In conjunction with the finding of rare variants, the results of this proposal are expected to support investigations in translational research, more specifically in terms of mechanisms of disease, development of biomarkers, and identification of possible targets for intervention and new therapies. 3. By fostering the career development of a researcher representative of a minority group, the diversity supplement would empower the candidate to become a strong representative of her minority group within her Institution and the nephrology community, fostering new similar initiatives, inspiring students and colleagues from similar backgrounds, and creating opportunities for mentoring within the diversity scope.